Vestibular and neck muscle contributions to head control in response to induced head perturbations and falls in balance-impaired older adults

PROJECT SUMMARY/ABSTRACT
Falls are common in older adults, and head (including face) and neck injuries are common and result in
significant morbidity. Yet, little is known about the mechanisms of control of the head and neck during a fall and
few interventions are directed toward limiting these injuries. This high risk/high reward approach is
fundamentally different from traditional approaches and measures head motion during lab-based falls in older
adults at risk for fall-related injury. We will leverage our experience of collecting fall impact data in older adult
participants to maximize safety in the current proposal. The ultimate goal of this innovative proposal is to set
the stage for the development of a novel approach(es) to reduce fall related head/neck injuries in older adults.
The current proposal seeks to determine whether motor or vestibular function and/or their combination
contribute to head control during falls. Our expert research team utilizing state-of the art assessments will
explore whether the vestibular system, specifically the sacculo-collic reflex (due to role in modulating reflexive
adjustments of the musculature in the neck) and/or neck mechanics (muscle strength, range of motion and
muscle activation) are related to head control during a fall. A secondary aim will explore relation between head
motion following laboratory-based head pull perturbation and head motion during a fall and if it is modified by
neck mechanics. Lastly, other potential factors such as arm use, gender, and abnormal balance/gait will also
be explored. A total of 30 older adults (> 65 years of age) with balance impairment, and with varying vestibular
function will be enrolled. Participants will undergo a series of standardized tests including comprehensive
vestibular assessments, neck mechanics assessment and backward and sideway falls. During all of the tests,
head motion and neck muscle activity will be quantified utilizing validated techniques. Studying the links
between vestibular function, neck mechanics, and head control in an actual fall provides a better
understanding of the mechanisms contributing to head and neck injury and eventually points to better-directed
therapies to decrease this injury risk. Preliminary data from this high risk/high reward project will direct larger,
more appropriately powered and more definitive testing of the mechanisms underlaying head control during
falls.

Public health relevance
PROJECT NARRATIVE This proposal has considerable importance for public health as the results will provide information concerning the control of the head during actual falls in older adults. Investigating the mechanism(s) relating to head control during actual falls will lead to better-directed therapies to decrease fall-related head injury risk.